FACTORS CONTRIBUTING TO IMPROVEMENT OF MALIGNANT BILIARY OBSTRUCTION

A retrospective study to evaluate factors conributing to improvement of bile obstruction using a stepwise logistic regression analysis. Benefits from different surgical procedures will be compared.